Next Generation Temporal Interference Stimulation for Non-Invasive Neuromodulation

Electrostimulation (ES) is a versatile and efficient tool for interrogating, altering, and manipulating neural
activities in health and disease. Deep brain ES delivered with implanted electrodes requires an elaborate
neurosurgery and carries risks of tissue damage, bleeding, stroke, infection, and inflammation. This limits the
use of deep brain ES for disease diagnostics and conditions that may not justify the risks.
Non-invasive targeted deep brain ES has long been a major quest, with countless potential applications.
The challenge is avoiding stimulation near surface electrodes, where the electric field is the strongest, while
stimulating at a depth by a (much) weaker electric field. One way to stimulate at a distance is by temporal
interference (TI) of two high-frequency sine waves delivered with a small frequency shift. The interference of
two such waves creates an amplitude-modulated stimulus at the target. Assumed demodulation of this signal
by neurons leads to their excitation at the modulation frequency.
Here, we introduce an entirely different concept of the temporal interference, based on (a) complete
cancellation of identical frequency carrier signals at the target, and (b) on the introduction of transient
distortions in one or both these signals. The distortions, such as a brief frequency or phase shift, will be
concealed by the strong periodic signal near the stimulating electrodes and will not lead to excitation at the
surface. However, these distortions will add up at the remote target location. They will stand out from the
“silent” background and will readily lead to excitation despite the attenuation of the electric field with distance.
We will perform mechanistic studies which support this next generation TI (NG-TI) stimulation paradigm. We
will continue with the design and experimental evaluation of different NG-TI protocols in vitro, in comparison
with the “standard” TI. We will systematically analyze the impact of TI stimulation parameters, to achieve
targeted tuning and modulation of individual neurons and neuronal circuitry. We hypothesize that NG-TI can be
improved for more focal stimulation, with much better penetration. It will have lower electric charge stimulation
threshold and enable better steerability than the standard TI. The most efficient NG-TI protocols will further be
validated by in vivo animal experiments. We will qualitatively compare targeting, possible off-site effects,
current consumption, and steerability of NG-TI and the standard TI. We will also define the feasibility and
model the electric field parameters for NG-TI stimulation at distances useful for medical applications. The
effects will be linked to dielectric and physiological properties of neurons and neural tissue, to build predictive
models for non-invasive deep brain stimulation in large animal and human trials. This project will lay the ground
to translate the NG-TI technology for disease diagnosis and treatment.

Public health relevance
We will analyze cellular and membrane mechanisms of excitation of neurons by modulated periodic stimuli and introduce a novel paradigm of non-invasive deep brain stimulation. We will design, test, and tune new protocols for the next generation temporal interference stimulation. We will utilize the novel interference targeting protocols for neuromodulation selectively at a distance, for clinical applications such as non-invasive deep brain stimulation.